SAFETY AND EFFICACY OF ALENDRONATE SODIUM IN GLUCOCORTICOID INDUCED BONE LOSS

The goal of the study is to define the safety and tolerability of oral alendronate when administered for one year in glucocorticoid-treated patients. The study will also assess the effect of oral alendronate on spinal bone mineral in patients treated with oral prednisone.